IGF::OT::IGF Pharmacokinetic and Pharmacodynamic Studies for Medications Development; POP 9/14/12 - 9/13/17, FY12 N01DA-12-8905

The contractor is to conduct pharmacology/pharmacokinetic studies to support the development of new medications for the treatment of disorders stemming from tobacco, cannabis, cocaine, methamphetamine, or opiate use or abuse.